MCUAAAR Research Education Component

Research Education Core Abstract
There is a severe shortage of ethnic minorities at all levels of the bio-medical and social and
behavioral sciences workforce. African Americans, Latinos and Native Americans have a lower
likelihood of entering and completing college, graduate school, and professional schools.
Additionally, ethnic minority faculty members in the social and bio-medical sciences are less
likely to receive tenure or move to the highest levels of academic positions. One of the issues
identified in the literature that may substantially facilitate diversifying the academic and bio-
medical workforce is mentoring. We propose to build upon a proven method of “integrative”
mentoring which has allowed pilot investigators in the MCUAAAR to become productive
researchers and obtain NIA/NIH funding. The three specific aims of the Research Education
Component (REC) include: 1) Recruit and select 15 new junior researchers who propose pilot
studies using a biopsychosocial life-course framework for behavioral and social science studies
of aging and health disparities; 2) Coordinate the short and long term mentoring, retention, and
follow-up of this set of ethnic minority junior investigators whose research focuses on the social
and behavioral aspects of physical and mental health and health disparities; and, 3) Conduct
year-round training sessions, and implement curricula for research investigators and conduct
intensive three-day summer workshops for a national audience of junior minority faculty and
postdoctoral scholars. We have developed a structured mentoring and education process,
which includes an individualized development plan, monthly integrative and individual mentoring
sessions, and an educational series in research fundamentals and health disparities. Our
mentoring approach is enhanced through the integration of the Research Education Core with
the Administrative, Community Liaison and Outreach, and Analysis Cores. The MCUAAAR
faculty have developed a proven strategy to successfully mentor junior researchers, and the
MCUAAR faculty are active major researchers in the field of African American life-course
development and aging. Based upon this proven track record, the Michigan Center for Research
on Urban African American Aging Research is clearly well-suited to contribute to the
development of the next generation of RCMAR scientists.